A Personalized Digital Outreach Intervention for Lung Cancer Screening

Using annual chest CTs to screen for lung cancer, the leading cause of cancer death in the United States, can
reduce mortality by up to 20%; however, fewer than 4% of eligible Americans are screened. The US Preventive
Services Task Force endorses lung cancer screening (LCS) for high risk current and former smokers. At the
same time, LCS poses significant risks, such as false positives and invasive procedures. Accordingly,
guidelines recommend and Medicare requires that patients engage in a shared decision making visit prior to
screening. Unfortunately, primary care providers rarely discuss, and consequently patients rarely receive, LCS.
Patient, provider, and system barriers contribute to low LCS rates. Many patients are unaware that LCS exists,
that it is effective, or that they qualify for screening. The risks and benefits of LCS vary substantially according
to patients’ risk factors making general education about LCS difficult. Healthcare providers have poor
understanding of the screening criteria and lack the time and personalized information needed for shared
decision making discussions. Decision aids for LCS are a partial solution; they can increase patient
awareness, deliver personalized information, and help patients make a screening decision. However, they fail
to address many provider and system barriers. Our team has developed an innovative digital outreach strategy
called mPATH-Lung (mobile Patient Technology for Health – Lung) based on Social Ecological Theory and the
Integrative Model of Behavior. mPATH-Lung has multilevel functionality: it (a) queries the electronic health
record to identify potential screening candidates, (b) sends those individuals electronic invitations to visit a
web-based LCS decision aid that helps them make a screening decision concordant with their values, and (c)
empowers patients to electronically request an LCS clinic appointment for the mandated shared decision
making and subsequent screening. Electronic program summaries are sent to patients and providers, ensuring
shared decision making visits occur with informed participants. This project will determine the impact of
mPATH-Lung on patient decision making and receipt of LCS in a pragmatic randomized controlled trial using a
mixed methods design. The Specific Aims of the proposal are to: 1) Determine the effect of mPATH-Lung on
receipt of LCS in a pragmatic randomized-controlled trial of 1318 primary care patients in two large health
networks with a catchment area extending to 5 states; 2) Elucidate the drivers of patients’ LCS decisions and
screening behavior using a values clarification exercise and semi-structured interviews with at least 60 patients
selected to represent the spectrum of decision-behavior concordance; and 3) Explore implementation
outcomes that will impact the sustainability and dissemination of mPATH-Lung using program data, surveys,
and interviews. This project could decrease lung cancer morbidity and mortality by broadening the use of LCS
while simultaneously supporting patient-centered care. Importantly, our digital outreach design could have
broad applicability to other health conditions, expanding the impact of this proposal beyond LCS.

Public health relevance
Screening for lung cancer reduces lung cancer mortality but fewer than 4% of eligible Americans get screened, and lung cancer remains the leading cause of cancer death in the United States. mPATH-Lung is an innovative digital outreach program that identifies patients who qualify for lung cancer screening and helps them get screened. This project will determine how mPATH-Lung affects patients’ screening decisions and their completion of screening, potentially reducing the number of people who die from lung cancer.